AN ANTI-P24 MONOCLONAL ANTIBODY CROSS-REACTIVE WITH MANY HIV-1 PROTEINS

We produced three murine antibodies (mAbs) against the HIV-1 proteins. These mAbs, namely CA-1, CA-2, CA-4 were IgG1 and all reacted with p24 on the HIV-1 western blot. One of the mAbs, C-4, also recognized p13, p2l, p28, p29, p32, p39, p47 and p55 on the Biotech/DuPont HIV-1 western blot strips and p2l, p24, p28, p29, p39, p47, p55, p68, p8O, p96, and p110 on the Bio-Rad strips. CA-4 did not react with H-9 cell lysate nor with other retroviral antigens such as HTLV-1 or HIV-2 proteins. The binding of CA-4 to HIV-1 proteins was not blocked by deglycosyation. All three mAbs reacted with recombinant DNA derived capsid protein (p24) of HIV-1. These results suggest that many proteins in the HIV-1 western blot contain antigenic epitope(s) similar to that of p24.